Targeting FOXP3 mRNA splicing for breast cancer immunotherapy

Project Abstract
The development of cancer immunotherapy including immune checkpoint inhibitors and adoptive cell transfer
(ACT)-based therapies revolutionized cancer treatment. The success, however, is limited to a relatively small
subset of patients and cancer types. Regulatory T cells (Tregs) play a central role in maintaining immune system
homeostasis and negatively regulate immune-mediated inflammation such as autoimmune diseases, asthma
and allergy. However, tumor infiltrating Tregs also suppress effective anti-tumor immunity. FOXP3 is a master
regulator of Treg development and function. Human FOXP3 gene encodes two major isoforms through mRNA
alternative splicing – a long full-length isoform (FOXP3L) and a shorter isoform lacking exon 2 region (FOXP3S).
To study the function of FOXP3S in Tregs, we generated a Foxp3S mouse line expressing only the Foxp3S
isoform. Our preliminary studies with orthotopic mouse breast tumor models demonstrate that the Foxp3S mice
are completely resistant to tumor development, while the littermate wildtype mice expressing Foxp3L exhibit
significant tumor growth. Intratumoral injection of Foxp3S-promoting morpholino drug (MO) into the breast
tumors in wildtype mice markedly increases IFN-γ+ CD4 and CD8 T cells in the tumors and thus suppresses
tumor growth. Interestingly, bioinformatics analysis of transcriptomic data from The Cancer Genome Atlas
(TCGA) reveals that FOXP3S mRNA expression in human breast cancer is positively correlated with clinical
outcomes. Given that over 60% of tumor-infiltrating CD4 T cells are Tregs and the most dominant TCRs from
intratumoral Tregs were tumor-reactive and recognize specific tumor neoantigens, we hypothesize that
promoting FOXP3S isoform expression will reprogram tumor-reactive Tregs and convert these immune
suppressive Tregs to tumor-specific T helpers thus promoting antitumor immunity. We propose to use unique
mouse lines, FOXP3S-promoting morpholinos and patient-derived organoids to test our hypothesis. We will
determine the mechanisms for FOXP3S-mediated antitumor immunity and further define the efficacy of FOXP3S-
promoting morpholinos in breast cancer treatment. Successful completion of this study will identify a novel
therapeutic strategy for breast cancer immunotherapy.

Public health relevance
Project Narrative-Relevance to Public Health Tumor-infiltrating regulatory T cells (Tregs) suppress effective immunity against breast tumors. We propose to develop a novel morpholino-based drug to direct FOXP3S isoform expression in Tregs and test its efficacy in breast cancer immunotherapy. This research will integrate Treg functions into precision medicine to fuel exciting translational development in breast cancer immunotherapy.